New Hampshire IDeA Network of Biomedical Research Excellence (NH-INBRE)

Abstract
This application for renewal of the grant supporting the New Hampshire IDeA Network of
Biological Research Excellence (NH-INBRE) proposes to 1) support engagement of PUI-P
students in biomedical research to expand research and career development.; 2) increase
success obtaining external biomedical research funding at R15 eligible NH-INBRE institutions; 3)
improve statewide data science capabilities, education, and infrastructure; and 4) facilitate
collaborations within and outside the NH-INBRE network that support prior aims and biomedical
research within and outside NH. The components and organization of the Network are described
as is the progress made during the first 14 years.
The Geisel School of Medicine at Dartmouth will continue to be the Lead institution and house
the NH-INBRE Administrative Core. The University of New Hampshire at Durham will also
continue as the Co-Lead institution. The proposed Partner institutions include 8 four-year primarily
undergraduate institutions and the Community College System of New Hampshire. NH-INBRE
will be led by a team of accomplished faculty, all of whom direct active, federally-funded research
laboratories. A team of multiple faculty, administrators and evaluators constitutes the
Administrative Core (AC) of NH-INBRE and will be led by Principal Investigator Dr. Steven Fiering.
This team-based approach, rather than relying solely on the Principal Investigator and Program
Coordinator, has proven effective in establishing NH-INBRE and initiating diverse programs.
Different components of NH-INBRE, including Cores and the Developmental Research Projects
Program, will collaborate to achieve the goals of NH-INBRE and Internal Independent Evaluation
will evaluate all our programs. A wide variety of metrics will be used for ongoing evaluation and
improvement of NH-INBRE. The plan is centered on the belief that original scientific research is
crucial for scientific training of college students, and expanding the participation of students and
faculty at Partner institutions in original scientific research on their campuses is essential for
fostering a culture of biomedical research within New Hampshire's institutions of higher education
and the state overall.

Public health relevance
Narrative The human resource of trained researchers are a crucial component of successful biomedical research that can improve health and healthcare. Currently, many potentially productive researchers coming out of undergraduate science training choose careers outside science because they have not experienced and do not understand scientiﬁc research, which is the central function of a scientist. Similarly, at primarily undergraduate colleges, the research conducted by fully research-trained faculty is limited by inadequate resource investment. NH-INBRE’s programs will support development of these underutilized human research resources and increase the research training and scientiﬁc productivity of the workforce in New Hampshire.